The role of the gut microbiome in ICB-induced anti-tumor response and toxicity

PROJECT SUMMARY
Immune checkpoint blockade (ICB) has transformed clinical oncology by inducing durable responses and
increasing survival rates in many types of cancers, including melanoma. However, only a subset of patients
benefits, and it is unclear what determines a patient’s response to therapy. In addition, ICB can lead to immune-
related adverse events (irAEs) that limit therapy and cause off-target tissue toxicities. Combination therapy with
anti-cytotoxic T-lymphocyte associated protein 4 (-CTLA-4) and anti-programmed death ligand 1 (-PD-L1)
exhibits the strongest efficacy, in terms of survival, compared with single agent treatments, yet this is associated
with a greater irAE frequency. Recent studies have delineated roles for the gut microbiome in serving as a
biomarker of ICB responsiveness, a potential therapeutic, and in some cases association with irAEs. With this
proposal, we aim to increase understanding of the gut microbiome-immune system axis in combination ICB
therapy. Recent work from our lab has highlighted roles for dendritic cells (DCs), professional antigen-presenting
cells (APCs) of the immune system, in ICB response as well as ICB-associated irAEs. Moreover, we found that
modulation of the gut microbiome via antibiotic treatment altered response to -CTLA-4: use of metronidazole
prior to ICB resulted in ~90% tumor regression upon -CTLA-4 treatment without intestinal irAE. In addition, the
efficacy of -CTLA-4 in metronidazole treatment conditions was associated with increases in type 1 conventional
DC (cDC1) amounts and activation status, consistent with prior clinical studies implicating a role for cDC1s in
favorable ICB response in melanoma patients. Thus, we hypothesize that specific microbes within the gut
microbiome induce increased activity of cDC1s, which regulate favorable responses to ICB treatment
and, upon dysregulation, contribute to ICB-mediated colitis. We propose to examine this hypothesis in two
aims. In Aim 1, we will identify the role of APCs in linking the gut microbiome to ICB-mediated anti-tumor
immunity. We will utilize fecal samples from melanoma patients to repopulate the gut microbiome of antibiotic-
treated mice (fecal microbiome transplantation, FMT). We will evaluate microbiome composition, immune cell
profiles, and intestinal inflammation (irAEs) in melanoma-bearing mice treated with combination ICB. In addition,
mice with a deficiency of cDC1s will be used to examine roles for this subset of APCs in ICB response and
toxicity following FMT with patient-derived material. In Aim 2, we seek to characterize the relationship between
metronidazole and effect on the microbiome and ICB response. We will utilize FMT with patient-derived material
from non-responders and metronidazole treatment to examine whether depletion of anaerobic bacteria via
metronidazole is sufficient to convert a non-responder into a responder. We will further examine the microbiome
composition and identify links to immune cell status and activity upon metronidazole treatment. Our studies will
delineate whether specific microbes from human fecal samples correlate with key immune signatures or irAEs,
thereby deepening understanding of mechanisms by which the gut microbiome regulates ICB responsiveness.

Public health relevance
PROJECT NARRATIVE Immune checkpoint blockade (ICB) has revolutionized the field of cancer therapy, yet a multitude of patients fail to benefit from this breakthrough treatment. The gut microbiome plays a key role in tumor immunity and response to ICB, but the specific mechanism(s) by which it regulates ICB response is unknown. Elucidating links between the innate immune system, the gut microbiome, and ICB response will be crucial to understanding the varied patient responses observed in the clinic and to improving patient outcomes.